Communications/Dissemination Core

PROJECT SUMMARY/ABSTRACT
The overall purpose of the CEC's Communication and Dissemination Core (CDC) is to create an infrastructure
to develop and refine processes and products to convey information to internal audiences (within the DPC) and
to external communities (broader educational institutions, diversity researchers, and policymakers) to share
DPC evaluation outcomes and increase the visibility and uptake of products, lessons learned, best practices,
and processes generated by the DPC. In addition, the CDC will enhance necessary internal communication
processes to assure the optimal functioning of the DPC. It will also strategically support communication about
and dissemination of products and processes to promote the best practices of consortium-wide programs
including those for the CEC, BUILD and NRMN programs. The CDC will provide an important support function
to the planned dissemination activities that will be identified by BUILD sites. The CDC will lead dissemination
efforts for CEC-based evaluation outcomes, best practices and key processes in evaluation, measurement,
and outcomes from its work in the DPC. The CDC will fulfill its purpose by executing these specific aims:
1) Refine DPC communication processes through collaborative planning with the DPC and NIH to develop and
support dissemination of DPC site level and consortium-wide best practices; 2) Develop and support
dissemination strategies to share CEC best practices, research outcomes, systems and tools among a variety
of national stakeholders in diversity education and training, biomedical and health professional science
research, and program evaluation; and 3) Support and amplify BUILD site-level plans for outcomes, products
and process dissemination, to increase the visibility of best practices among a variety of stakeholders
nationwide in higher education, biomedical and health professional science research dedicated to diversity
education and training, and policy.